Validation of The Environmental Audit Scoring Evaluation (EASE) Tool

SUMMARY PAR-19-071/NOT-AG-18-056 calls for “Identifying best models of care in LTSS settings (design, organization, financing) to maintain quality of life for PWD and their caregivers.” Person- Centered Care (PCC), which is emerging as a preferred model of care for long-term care, promotes choice, purpose, meaning and deep relationships as a part of daily life. Alongside the evolution of PCC has been the development of the household model of design, which seeks to recreate the core elements of a home environment for residents to live in. A major limitation to identifying the “best environmental model” is the lack of standardized definition of, or tool to measure, the homelike character of a long-term care setting. This project will validate a newly developed tool, the Environmental Audit Screening Evaluation (EASE) which is specifically focused on the household model design, and was developed from several comprehensive reviews of the research on designs for individuals living with dementia. No other existing tool provides the specificity or evidence-based foundation for this approach to designing long-term care settings. The two most commonly used US-based tools are either not household-focused or don’t measure specific elements of the environment. Using a sample of 15 nursing homes that are all moderate to deep adopters of person-centered care and which are stratified to reflect three distinct design styles (traditional/institutional, partial household/neighborhood, and full household model) the EASE will be validated against the Therapeutic Environment Screen Scale, the Professional Environmental Assessment Protocol and the Environmental Audit Tool, and reliability will be assessed. This is in preparation for a future study to use the EASE to identify which specific aspects of household design are most highly correlated with a variety of resident (clinical, psychological, well-being and quality of life), staff (satisfaction, turnover, etc.), family (satisfaction) and organizational outcomes (payor mix, quality ratings, etc.).

Public health relevance
PROJECT NARRATIVE This project will assess the validity and reliability of the Environmental Audit Screening Evaluation (EASE) against three validated environmental assessment instruments. The EASE is an evidence-based tool designed to evaluate the discrete elements of household design in long term care settings in a manner no other assessment tool does. This level of specificity is necessary to advance our understanding of the role of different aspects of the designed environment on a variety of quality indicators and outcomes.